The Neuro-Imaging Core

The goal of the imaging core is to collect, de-identify, transfer, and store, brain imaging from participating SPOTRIAS subjects, particularly subjects entered into the SPOTRIAS Trials (CLEARER, STOP-IT, and MR Rescue). Dr. Thomas Tomsick will also be the central reviewer for all imaging studies in the CLEARER Trial as he did for the CLEAR Trial. One of the goals of the next five years of this core for all SPOTRIAS Centers is to develop a shared database of de-identified image data, linked to phenotypic and genetic data that can be used by SPOTRIAS network investigators as well as other investigators. Specific goals include: 1. Collect, de-identify, transfer, and store images related to University of Cincinnati directed projects (CLEARER and STOP-IT as well as to collect and transfer images from other SPOTRIAS projects in which DC participates (MR Rescue). 2. Review and record imaging results for all brain imaging done as part of the CLEARER Trial (Dr. Tomsick). 3. Maintain local SPOTRIAS/MR RESCUE imaging workstation. 4. Collaborate with other SPOTRIAS centers to implement a shared imaging database.